DENDRITIC CELLS OF RAT HEART IN EXPERIMENTAL MYOCARDIAL INFARCTION

This is the first report documenting the presence of dendritic cells among the components of the cellular reaction in the border zone of a myocardial infarct. The significance of these cells is not understood clearly, and further studies will be necessary to determine their functional role in the pathophysiology of myocardial infarction.